Developmental Research Project Program Project

Developmental Research Project Program
Project Summary
The Developmental Research Project Program (DRPP) program's overall goals are to support the most
promising research at Primary Undergraduate Institutions (PUIs) by developing, establishing, and maintaining
the research capacity and culture on the campuses; promoting the career development of targeted faculty; and
providing opportunities for undergraduates to have meaningful research experiences. DRPP support will build
research capacity by providing PUI faculty 50% release time to engage in significant research, and funding for
material support of the laboratory in terms of supplies and equipment. Each DRPP faculty member receives
mentoring (science and career) from senior faculty on her/his campus as well as through regular communication
with an appointed Research Institution (RI) mentor. The enhanced research capacity of DRPP-supported faculty
directly influences the overall research environment on campus, primarily through research and scholarly activity
required for DRPP funding but also owing to activities such as journal clubs, lab meetings, and campus-wide
symposiums that highlight the research of students in all Science, Technology, Engineering, and Mathematic
fields. DRPP projects provide opportunities for greater numbers of undergraduate students (both INBRE- and
non-INBRE Scholars) to join the NE-INBRE supported laboratories, thus generating a pipeline of undergraduates
that funnel into biomedical research and health professional careers. All DRPP projects are aligned with the
network's scientific themes of Infectious Diseases, Cancer Biology, and Cell Signaling and thus serve to facilitate
communication, promote research collaborations, and enhance mentoring activities that occur between faculty
at the RIs and PUIs. DRPPs are the very threads linking research activities within the network. The Senior
Executive Committee and External Advisory Committee will facilitate successful implementation of the awarded
DRPPs through annual evaluations.